REGRESSION OF HYPERTENSIVE LVH IN AFRICAN AMERICANS

The purpose of this study is to gather data to support the hypothesis that excess dietary salt in the salt sensitive phenotype activates cellular events in the volume control systems that result in increases in blood pressure, myocardial cell hypertrophy and relative coronary microvascular ischemia.